Research Capacity Building Core

SUMMARY – RESEARCH CAPACITY BUILDING CORE
The Research Capacity Building Core (RCBC) is an integral component of the Drexel Center on Climate
Change and Urban Health and will support its central theme: “the creation and dissemination/translation of
evidence that will support urban policies to address the health and equity impacts of climate change in cities.”
In support of this theme, the overarching objective of the RCBC is to increase capacity to conduct policy-
relevant research on the health and equity impacts of climate change in cities, among researchers with
extensive expertise in urban health research. The RCBC is designed to increase such research capacity by
building on existing strengths at the Drexel Urban Health Collaborative and our partner sites, including: (a)
extensive experience in urban health, inter- and intra-urban health inequities, racial/ethnic disparities
inequities, social determinants of health and environmental health broadly defined; (b) demonstrated
engagement in transdisciplinary research; (c) capacity to translate research findings to policy audiences; and
(d) a long history of cultivating a diverse research workforce. Capacity strengthening activities will include
structured workshops, webinars, journal clubs, and working groups. The RCBC will also conduct
transdisciplinary research that combines methods used in climate-and-health science with methods used in
urban health research, and catalog and support the use of research methods (both study designs and
analytical approaches) available to urban health researchers that can be used to address novel questions
about the impact of climate change on urban health and health equity. In addition, it will collaborate with the
Administrative Core and Community Engagement Core to solicit, award and support pilot projects. The RCBC
will provide integrated biostatistics and study design support for the use of pilot study findings as preliminary
data in new grants and will provide methodological support for grants development more generally. The
Specific Aims of the RCBC are: (1) To increase urban health researchers’ capacity to conduct transdisciplinary
research on climate change and urban health by strengthening content area knowledge on climate change,
strengthening and leveraging their research design and analytical skills; and expand their skills to engage in
transdisciplinary research and integrate policy needs into the development of solutions-oriented research
questions about climate change. (2) To develop, translate and support the use of research methods and
designs to examine inter- and intra-urban variation in health impacts of climate change; and (3) To strengthen
systems and structures to develop new transdisciplinary projects on the impacts of climate change on health
by awarding and supporting pilot/feasibility studies that engage multiple disciplines, and supporting
methodological aspects of new grant development. Ultimately, the RCBC will strengthen capacity to conduct
impactful, policy-relevant transdisciplinary research on climate change and health and health equity in cities.